Global HIV/AIDS Vaccine Enterprise

Recognizing the need for increased cooperation, 30+ international organizations joined forces, forming the Global HIV Vaccine Enterprise (Enterprise), a voluntary alliance of public-and private-partners committed to working together, while maintaining independent decision-making authority. The Enterprise Secretariat (Secretariat) is a small organization that dedicates resources to facilitate coordination, collaboration, knowledge sharing, and resource optimization among the Enterprise. As a non-biased broker, they facilitate collaboration and strategic decision-making in an even-handed, transparent way. As an established and trusted organization undertaking projects on behalf of the Enterprise since 2008, the Secretariat provides resources for strategic problem solving, for leading special projects and for progress in collaboratively determined focus areas.